Head and Neck Cancer Immunology Administrative Core

SUMMARY – ADMINISTRATIVE CORE
The purpose of the Program Administration Core is to provide support for the Integrated Program on
“Strategies to Overcome Immune Resistance in Head and Neck Cancers.” The Core Director (Dr.
Pai) and co-Director (Dr. Wirth) will provide guidance and oversight to the Projects and shared Cores
and will lead the evaluation of research progress including consultation with Internal and External
Advisory Boards. The Administration Core will coordinate the inter-related complementary research
projects to maximize their scientific synergy and to share the findings with the broader scientific and
clinical communities. The Core will provide assistance to Projects, including administrative support,
regular project review meetings, support for manuscript preparation, project evaluation, and scientific
communication. The ultimate goal of the Program is to translate immune based discovery into new
therapies for patients with head and neck cancer through the testing and validation of novel
therapeutic agents in preclinical models prior to its translation into patients.